Overcoming multidrug-resistance in hookworms

Project Summary
Ancylostoma caninum causes cutaneous larva migrans and eosinophilic enteritis in
humans. The reason these human diseases cannot be eliminated is because the
parasite persists in the canine reservoir host. Multi-drug resistant isolates of A. caninum
are now circulating in the United States. In addition, specific life cycle stages (tissue-
dwelling larvae) are tolerant of anthelmintics even when the isolate is considered “drug
susceptible.”
Our hypothesis is that A. caninum evades drug treatment with permeability
glycoproteins (P-glycoproteins) that efflux anthelmintics and prevent them from binding
target receptors. In this application we propose to 1) identify the spectrum of
anthelmintics enhanced by P-glycoprotein inhibition in A. caninum, 2) record the
repertoire of Pgps expressed in response to each drug class, 3) map the precise tissues
where Pgps are expressed, 4) characterize the pharmacological profile of Aca-Pgp-11,
and 5) empirically determine regions of specific sites of nematode P-glycoprotein that
could be exploited. Our results will inform future studies testing the hypothesis that
nematode-specific P-glycoprotein inhibitors can be used to restore efficacy of multiple
existing anthelmintics and overcome drug resistant Ancylostoma.

Public health relevance
Project Narrative This project addresses the problem of drug resistance in the zoonotic hookworm parasite Ancylostoma. The aim of the project is to characterize a new parasite-specific drug target that can be exploited to overcome multi-drug resistance. The project is relevant to the NIH mission of protecting the public from eukaryotic infectious diseases, such as parasites.